Hormonal Tuning of Specific Circuit States from a Well-Defined Connectome

Project Summary
We aim to establish that only specific circuit states of an identified connectome are modulated by circulating
hormones. Different circuit states are ones with at least some circuit neurons expressing modified cellular
(ionic currents) and synaptic properties. Most cellular-level mechanistic studies of circuit state modulation have
come from in vitro studies using arbitrary parameters or concentrations to stimulate individual modulatory
neurons or apply one or two neuromodulators. Thus far, little is known about the full complement of effective
modulators, such as within a population of hormones, during a specific behavioral state and whether they
influence all circuit states of a given connectome. We aim to bridge this gap by merging access to two defined
circuits in the isolated nervous system with our ability to deliver a natural source of hormones. We will
determine the response of different gastric mill (chewing)- and pyloric (passage of chewed food) circuit states,
configured by different applied neuromodulators, in the isolated crab (Cancer borealis) stomatogastric ganglion
(STG) to hemolymph ('blood') obtained from an unfed crab. By using the fully functional circuits in the isolated
STG, the direct influence of hormones can be determined without a background of variable, spontaneous
projection neuron influences. Our pilot data support the hypothesis that hormones from a single behavioral
state tune the output of only certain circuit states. Specifically, hemolymph from unfed crabs strengthens the
gastric mill rhythm and its regulation of the pyloric rhythm when configured by the peptide Gly1-SIFamide [G-
SIFamide] or CabTRP Ia [CabTRP]. These effects of unfed hemolymph occurred without any qualitative
change in circuit activity. In contrast, unfed hemolymph did not alter the STG circuit states configured by the
peptide proctolin or the muscarinic acetylcholine agonist oxotremorine. Using these four applied modulators
and hemolymph from unfed crabs, we aim to (a) fully characterize each circuit state response, (b) identify each
hormone influencing a particular circuit state, including determining their hemolymph concentration and
comparing their separate and combined influence to whole hemolymph, and (c) determine the underlying
cellular and synaptic mechanisms. To these ends, we will use electrophysiology to monitor and manipulate
circuit neuron activity, and mass spectrometric (MS) analyses for hormone identification and hemolymph
concentration. Because unfed hemolymph enhances without otherwise altering the G-SIFamide and CabTRP
actions, we hypothesize that the active hormone(s) either activate the same ionic current(s) as the applied
peptide, or they enhance the effective concentration of each peptide by inhibiting their cleavage. We will use
voltage- and dynamic clamp to test the ionic current hypothesis, and MS analysis to identify each peptide's
cleavage products and determine if their amount is reduced in hemolymph. A successful outcome will extend
the available insight into the selective influence of the hormonal environment from particular behavioral states
on different circuit states of a well-defined connectome at the cellular, synaptic and circuit level.

Public health relevance
Project Narrative This proposal aims to extend the cellular, synaptic and circuit level understanding of circuit state modulation from studies of an individual hormone action on a single circuit state to the impact of a complete hormonal environment from a particular behavioral state on several different circuit states from the same defined connectome. We aim to address this issue by studying the fully-defined motor circuits in the isolated crab (Cancer borealis) stomatogastric ganglion, using a multi-disciplinary approach that combines electrophysiological manipulations of identified circuit neurons with mass spectroscopic identification of individual hormones and their biologically relevant concentrations. Insofar as the neural circuits in many, and perhaps all, animals are configured via neuromodulation into different circuit states, and no previous study appears to have addressed this issue at the level proposed herein, a positive outcome from the proposed experiments will contribute to fundamental knowledge about the nature and behavior of living systems.